Establishment of the meiotic cell cycle program through post-transcriptional regulation by MEIOC and YTHDC2

PROJECT SUMMARY/ABSTRACT
Diploid germ cells are transformed into haploid gametes via the reductive division of meiosis. After meiotic
DNA synthesis, germ cells enter meiotic prophase I, which distinguishes itself from mitotic prophase by two
major characteristics. First, meiotic prophase I is dramatically longer than mitotic prophase. Second, meiotic
prophase I involves an intricate series of chromosomal events that contribute to the establishment of the
haploid state. The extended length of prophase I is critical for the completion of these chromosomal events, as
premature exit from prophase I causes recombination defects and chromosome mis-segregation. In mammals,
meiotic prophase I is prolonged by Meioc and Ythdc2. In the absence of either gene in both males and females,
meiotic germ cells fail to complete meiotic prophase I and prematurely enter an abnormal metaphase before
ultimately apoptosing. Several preliminary observations suggest that MEIOC and YTHDC2 function as a
complex to post-transcriptionally regulate cell cycle factors within meiotic germ cells. MEIOC and YTHDC2 are
first expressed in the germ line at meiotic initiation, and they interact with one another as well as with an
overlapping set of transcripts, including key cell cycle regulators. These targets are enriched for the RNA
modification N6-methyladenosine (m6A), which is preferentially recognized by YTHDC2's YTH domain and
which is used to target and post-transcriptionally regulate RNA. In the absence of Meioc, MEIOC and
YTHDC2's targets exhibit reduced stability. Changes in transcript stability are oftentimes accompanied by
changes in translation, and in HeLa cells, YTHDC2 enhances translational efficiency while decreasing mRNA
abundance. However, it remains unknown whether MEIOC and YTHDC2 affect translation in meiotic germ
cells. This proposal will test the hypothesis that MEIOC and YTHDC2 function as a complex to recognize and
translationally regulate m6A-modified mRNA in order to establish a meiosis-specific cell cycle program. This
hypothesis will be tested via three specific aims. The first aim will assess MEIOC's ability to affect YTHDC2's
interactions with RNA, particularly cell cycle-related transcripts, by identifying the transcripts that YTHDC2
binds to in the presence and absence of Meioc. In addition, whether m6A contributes to MEIOC and YTHDC2's
ability to interact with RNA will also be assessed. The second aim will identify the translational changes that
occur as germ cells transition from mitosis to meiosis, as well as between wild-type and Meioc-null samples. In
particular, this aim will determine whether cell cycle factors are translationally repressed at the onset of meiosis
and by the upregulation of Meioc. The third aim will determine whether MEIOC and YTHDC2 are continuously
required during meiotic prophase I to prevent precocious cell cycle progression, as well as identify the
mechanistic regulation behind this putative requirement. Collectively, these fundamental studies on MEIOC
and YTHDC2's regulation of the length of meiotic prophase I will provide key insights into the establishment
and regulation of the meiotic cell cycle program, with broader implications for fertility, development, and cancer.

Public health relevance
PROJECT NARRATIVE Procreation is a fundamental aspect of life that occurs when a sperm fuses with an egg. The disrupted formation of sperm and eggs, also known as germ cells, can result in infertility, spontaneous abortions, and birth defects, yet many aspects of germ cell development remain poorly understood. The goal of this proposal is to study the regulation of meiosis, a specialized cellular division that is required to produce haploid sperm and eggs, using mouse as the model organism, and discoveries made from this work will provide insights that are relevant to human health and fertility. !